Development of wearable monitor to detect decompensation in cardiac failure patients

PROJECT SUMMARY
Heart failure is a chronic condition in which the heart muscle can’t pump enough blood to meet the body’s needs
for blood and oxygen. Heart failure affects over 5 million Americans and it is a serious condition that can be life-
threatening if left untreated. Decompensated heart failure is the leading cause of hospital readmissions in the
US. A common symptom of decompensation is the development of peripheral edema. Detecting edema can
provide important clinical information to healthcare providers regarding the severity of the patient's heart failure
and help guide treatment decisions. However, currently patients are asked to watch for edema themselves by
checking their weight or noticing swelling of the legs/ankles and signs are often missed until the late stages of
decompensation. In this context there is a need for a remote monitor that can offer an earlier warning and permit
telehealth interventions to reduce hospital readmissions. Using our previously developed FlexNIRS platform we
propose to build and validate a multi-wavelength wearable edema and microcirculation monitor and conduct a
pilot clinical trial in patients admitted due to decompensate cardiac failure in which we will seek to demonstrate
that physiological parameters related to re-compensation can be followed non-invasively and thus support the
future conduct of larger scale studies of at home monitoring to detect decompensation.

Public health relevance
PROJECT NARRATIVE Heart failure impacts more than 5 million Americans and is the leading cause of short term hospital readmissions. Current methods to detect cardiac failure decompensation at home rely on patient’s self-report and are lacking, motivating the need to develop non-invasive remote monitoring technology that could be widely disseminated to allow earlier intervention and reducing the rehospitalization rate. We propose to develop a wearable monitor that uses near-infrared light to detect excessive accumulation of water in tissue (edema) as well as impaired peripheral blood circulation and demonstrate its utility in pilot clinical study in patients with cardiac failure.